REVACCINATION OF NONRESPONDERS TO PREVENT VACCINATION WITH HBMP OR RECOMBIVAX HB

Comparison of 10 mcg. dose of Hepatitis B Mixed Particle Vaccine with 40 mcg. dose of Recombivax HB to minimize side effects in nonresponders.